Host integration of commensal and pathogenic bacterial-derived signals

PROJECT SUMMARY
Enteric bacterial infections remain one of the greatest public health challenges worldwide and deciphering the
mechanisms that protect against infection will enable development of new treatments. Intestinal tissues are in
constant direct contact with diverse beneficial and pathogenic microbes, highlighting the need for orchestrating
complex microbial signals to sustain protection against infection. Intestinal epithelial cells (IECs) reside at the
direct interface between intestinal pathogens, beneficial commensal bacteria, and intestinal immune
components. However, despite continuous exposure to diverse microbes, the mechanisms regulating how IECs
integrate microbial-derived signals to mount protective host responses to pathogens are not well understood.
The goals of this proposal are to interrogate how specific commensal bacterial-derived metabolites are sensed
by IECs to protect against pathogenic infection. Employing Citrobacter rodentium, a murine model of human
enteropathogenic Escherichia coli infection, our studies have identified that microbiota-derived products protect
against intestinal damage and enteric bacterial infection. Our epigenetic analyses for this project led to
identification of new commensal bacterial-derived metabolites that can directly regulate IECs and prime host
defense against pathogenic bacterial infection. Employing an exciting array of transgenic animals, pathogenic
and commensal bacterial strains, and human intestinal organoids, three specific aims are proposed that will (i)
decipher how the host calibrates intestinal barrier function by sensing newly-identified commensal bacterial-
derived metabolites, (ii) investigate metabolite-dependent regulation of enteric infection, and (iii) interrogate how
metabolism of dietary components by commensal bacteria prime the epigenome and enhance host response to
pathogenic bacteria. Defining pathways that integrate commensal and pathogenic signals will provide a
framework to test the therapeutic potential of manipulating commensal bacterial-derived metabolites to promote
antibacterial immunity.

Public health relevance
Intestinal bacterial pathogens are a major cause of morbidity and mortality globally and a leading cause of death among children. The goals of this proposal are to understand how specific metabolites from bacteria regulate host epithelial cells to protect against intestinal bacterial infection. The outcomes of these studies will benefit human health because they will inform the design of new approaches for improving intestinal immunity to fight infection.